Comparing the Impact of Voluntary and Mandatory Bundled Payments on Disparities in Surgical Care

Project Summary
This study examines how bundled payments implemented via voluntary and mandatory participation impact
access and outcomes among vulnerable patients – evidence needed to inform policymakers about the broader
policy impact and whether to scale bundled payments through voluntary and/or mandatory participation. As the
largest payer for lower extremity joint replacement (LEJR), one of the fastest growing elective procedures in
the country, Medicare has implemented bundled payments in an effort to improve value. However, there are
marked disparities in access and outcomes for LEJR. Bundled payments could reduce or exacerbate LEJR
disparities for patients who are vulnerable based on race/ethnicity or socioeconomic status, and these effects
may vary by participation mechanism. Hospitals serving vulnerable patients may be less likely to participate in
voluntary bundled payment programs because of perceptions that cost and outcomes are harder to influence
among these patients. Different effects may occur among vulnerable patients in mandatory bundled payment
programs, in which hospital participation is based on policymaker perceptions about the likelihood of cost
savings. As a result, it is important for policymakers to understand whether and how access and outcomes
change differentially for vulnerable versus non-vulnerable individuals after hospitals initiate participation in
bundled payments. Additionally, understanding how observed effects vary by duration of participation,
continuation versus disenrollment in bundled payments, or safety-net status of hospitals are key facets of
understanding policy impact. We hypothesize that hospitals in bundled payments will be less likely than non-
bundled payment hospitals to be located in markets with a high proportion of vulnerable patients; that
compared to non-vulnerable patients, vulnerable patients will have a lower likelihood of receiving elective LEJR
after hospitals start participating in bundled payments compared to hospitals that do not participate; and that
compared to non-vulnerable patients, vulnerable patients will experience smaller increases in quality and
smaller decreases in utilization and cost after hospital participation in bundled payments.

Public health relevance
Project Narrative One policy intervention for improving the value of lower extremity joint replacement (LEJR) among Medicare beneficiaries is bundled payments, which Medicare has implemented among hospitals nationwide via voluntary and mandatory participation. Bundled payments could exacerbate or lessen existing LEJR disparities for patients who are vulnerable based on race/ethnicity or socioeconomic position. As a critical element in determining the broader impact of bundled payments on value and informing policymakers about options for scaling bundled payments nationally, this study will examine how the presence and mechanism of bundled payment participation impact access and outcomes for vulnerable patients.